ADDICT CAREER HISTORIES: PROCESSES AND PATTERNS

The proposed study is for the continuation of the secondary analyses of 1781 addict career histories (1441 men and 337 women) accumulated from four long-term followup studies of chronic addicts identified from admissions to the California Civil Addict Program and various Southern California methadone maintenance treatment programs. The comprehensive data base includes self-reported demographics, family characteristics, and complete drug histories. Retrospective longitudinal interviews covering a period from 12 months prior to first narcotic use to interview provide behavioral data about narcotics use, legal supervision status, crime involvement, drug trafficking, employment, marital status, and treatment episodes. Corroborative data were obtained from the official arreat and methadone maintenance treatment records for each subject and from a volunteerily provided urine specimen taken in interview. Data manipulation computer programs have been developed in the earlier studies which convert the data to a form suitable for statistical analysis. The analyses planned include: (1) assessing quantitatively the effects of methadone treatment termination using time series analysis (Box-Jenkins ARIMA); (2) determining the sociodemographic and personality correlates of "maturing out"; (3) applying a causal model for the relationship between narcotics use and crime to subgroups of addicts to further clarify the boundary conditions of the model; (4) applying multivariate techniques to examine sex and ethnic differences in addiction careers; (5) defining the characteristics and particular career patterns of those addicts who become addicted immediately as opposed to those who become addicted after a period of occasional use; and (6) exploring various statistical methodologies for typing addicts and the addiction patterns associated with these types. Other research issues may be examined if time and resources permit. Pending ideas concern: (1) discriminating those addicts who do well in treatment or under legal supervision; (2) an economic assessment of addict sources of income; and (3) examining the changing characteristics of addiction over time.